Molecular and Genetic Dissection of Brain Circuits Controlling Fever

PROJECT SUMMARY ABSTRACT
During an infection, animals exhibit adaptive changes in behavior and physiology aimed at increasing survival.
Although many causes of acute infection exist, a similar set of stereotyped symptoms occur, which includes
increased body temperature or fever, decreased appetite and increased lethargy. Both warm-­ and cold-­blooded
animals generate a fever in response infection suggesting that fever circuits are hard-­wired and highly
conserved, yet exactly how the nervous system alters body temperature and associated behavior in response to
infection remains unknown. We have identified a population of neurons in the preoptic area of the hypothalamus
that are highly activated following administration of inflammatory lipopolysaccharides (LPS). Due to the close
proximity between the organum vasculosum of the laminae terminalis (OVLT), where inflammatory cytokines
enter the brain to affect nearby cells, and neurons of the preotpic area regulating normal body temperature, and
our preliminary data, we propose that these newly identified LPS-­sensitive neurons control fever initiation during
an immune response. We will use chemogenetic activation and cell ablation approaches to demonstrate that this
population plays a role in increasing body temperature and in affecting other fever-­associated behaviors upon
LPS injection. Further, we have recently developed new approaches for molecular characterization of genetically
defined cell populations in situ using single-­cell RNA sequencing (scRNA-­seq) and multiplex, error-­robust,
fluorescent in situ hybridization (MERFISH) to generate a spatially-­resolved and functionally-­aware atlas of the
preoptic area. We will apply a similar strategy to characterize fever-­inducing neurons as well as surrounding non-­
neuronal cell types that are likely to play a role in fever generation through paracrine mechanisms. Finally, we
propose to use viral-­mediated tracing and functional tools to determine the direct and indirect circuit mechanisms
by which LPS-­sensitive neurons and their targets exert control over body temperature and fever-­related
behaviors. Our data will lead to a molecular and functional characterization of LPS-­sensitive neurons in the
preoptic area and to a better understanding of how inflammatory sickness symptoms, such as fever and related
behavioral changes, are regulated in the brain. These efforts have direct implications for understanding the
mechanisms underlying human sickness, and may inform new therapeutic strategies for the treatment of fever
and associated symptoms.

Public health relevance
PROJECT NARRATIVE During an infection, animals display a stereotyped set of symptoms aimed at increasing survival, such as elevation in core temperature aimed to fight pathogens (fever), decreased activity and appetite. Advanced molecular and genetic technologies allow for the dissection of dedicated neural pathways involved in specific physiological and behavioral responses, providing novel targets for diagnosis and therapeutic development. This proposal aims to leverage cutting edge molecular and genetics approaches to uncover the specific neuronal populations and neural circuits underlying the generation of fever and associated sickness symptoms.